Understanding the physiological roles of MOC efferent pathways for hearing in noise

This proposal investigates the underlying mechanisms of the medial olivocochlear (MOC) efferent system,
focusing on its role in anti-masking and the impact of hearing loss on its input and output pathways. To
leverage the potential benefits of the MOC system in hearing aids, it is essential to study the specific neural
mechanisms within the MOC system and how they are altered by hearing loss. The MOC system dynamically
adjusts cochlear gain based on multiple input pathways, including two major inputs from the inferior colliculus
(IC) and the cochlear nucleus (CN). While the CN input has been extensively studied, the IC input remains less
explored. IC cells in the midbrain are sensitive to low-frequency fluctuations (modulations) in auditory-nerve
(AN) responses, potentially conveying spectral information encoded within these fluctuations. Computational
modeling from my PhD thesis showed that this distinct information provided by the IC input to the MOC system
can explain auditory phenomena that cannot be fully accounted for by considering only the CN input. The
complexity and lack of detailed physiological data on MOC inputs, particularly from higher-level projections
such as the IC, underscore the need for innovative physiological methods and approaches. To address this
issue, this proposal outlines three specific aims, each involving novel physiological methods to isolate and
manipulate individual MOC pathways. The goal is to create a comprehensive dataset that significantly
enhances our understanding of the MOC efferent pathways. In Aim 1, we will explore the role of the IC input to
the MOC system by varying modulation frequency within a forward-masking paradigm, while simultaneously
recording transient-evoked otoacoustic emissions (TEOAEs) and envelope following responses (EFRs) to track
MOC-induced changes in cochlear gain and neural responses, respectively. This will provide a detailed
evaluation of the MOC efferent system, focusing specifically on the role of the IC input. Aim 2 will investigate
the relative role of the CN input to the MOC system by using a temporary threshold shift (TTS) noise exposure
animal model of cochlear synaptopathy, which will isolate the wide-dynamic range CN pathway while leaving
the IC input relatively unaffected. Finally, Aim 3 will examine the effects of sensorineural hearing loss (SNHL)
on MOC output projections to the outer hair cells (OHCs) by measuring how neural coding is influenced with
and without efferent electrical stimulation in both hearing-loss and normal-hearing animals. I have developed a
computational model of the MOC efferent system that integrates both CN and IC inputs during my PhD, which
guides the design and interpretation of our measurements. The proposed experiments will significantly
advance our understanding of the MOC system’s role in listening in noise and the broader effects of SNHL.
These findings will have implications for enhancing hearing-aid algorithms. The physiological training gained
through these aims will synergize with my computational background to provide a strong foundation for my
career as an independent researcher exploring translational issues related to listening in noise.

Public health relevance
Project Narrative The medial olivocochlear (MOC) efferent system includes downward projections from the brainstem to the cochlea and has been hypothesized to benefit listening in noisy environments. The proposed experiments aim to evaluate the relative roles of two input pathways to the MOC, as well as the effect of sensorineural hearing loss on the output projection pathway, and will have significant implications for improving hearing aid processing. The physiological training obtained through these experiments will synergize with my PhD training in computational modeling to establish a strong foundation for a career as an independent translational auditory neuroscientist.